Defining the Targets and Function of Direct Trigeminal Sensory Innervation to Salivary Glands

PROJECT SUMMARY:
Saliva is essential for oral and global health. The indispensable oral fluid - produced by salivary glands - facilitates
chewing, swallowing, speaking, and gustation. Loss of saliva (i.e. dry mouth) represents a significant health
burden, and can be caused by cancer treatments, medications (e.g. anti-hypertensives), or autoimmune
destruction of the gland. Patients report significant suffering when they lose saliva because they begin to
experience life-long morbidities, such as alterations in taste, loss of appetite, mucosal irritation and oral pain. To
date, additional treatments and therapies are needed to stimulate saliva production to alleviate dry mouth.
The autonomic nervous system is the primary controller of saliva production and release. However, the brain
and other neuronal components provide input to stimulate or inhibit these salivary autonomic neurons. Here, we
investigate a novel aspect of the nervous system that may influence salivary gland function: the trigeminal
somatosensory neurons that innervate the glands. We hypothesize that somatosensory neurons innervating the
gland respond to local stressors and influence saliva production. The overall objective of this application is to
use both small and large animal models to a) examine the glandular cell targets of the trigeminal sensory
innervation, b) define the molecular identity of gland-innervating sensory neurons, c) characterize the stimuli that
activate sensory neurons, and d) determine how sensory innervation influences saliva production. We will use
an array of powerful, cutting-edge approaches to develop a comprehensive view of these enigmatic neurons
across mammalian species.
Our studies will reveal new information on the topographical and molecular mapping of sensory innervation in
the gland, and the functional involvement of sensory neurons in saliva production. Ultimately, new therapeutic
strategies will develop from this work that target increasing saliva production in patients suffering from dry mouth.

Public health relevance
PROJECT NARRATIVE: Precise controlling and stimulation of neuronal-mediated saliva production is of eminent importance to an array of patients suffering from hyposalivation. In this project, the influence of somatosensory neurons on salivary flow and composition is determined with the prospect of paving the way for additional treatments that increase saliva production.